Mapping dynamic transitions across neural, behavioral, and social scales in interacting animals

Project Summary BBQS R34 – Zhang & Frohlich
Mapping dynamic transitions across neural, behavioral, and social scales in interacting animals
Human and animal behavior is shaped by many processes across spatiotemporal scales – from the activities
of neurons to the dynamics of social interaction. Mapping behavior and brain dynamics across scales is key to
a systemic understanding of cognition, neuropsychiatric disorders, and developing personalized interventions.
In social neuroscience, the mapping between social behavior and brain dynamics was primarily achieved by
constraining the behavior to a well-controlled, low-dimensional task space, where common linear statistical
methods suffice to discover cross-scale relations. However, the complex, dynamic, and interactive nature of
real-world social interaction is largely lost in such task-constrained settings. More recently, both human and
animal social neuroscience began to embrace a multi-brain interactive approach, where brain activities were
simultaneously recorded and found to be synchronized during live social interaction. Without task constraints,
animals can adopt and transition between a diverse range of behavioral patterns, which are signs of nonlinear,
high-dimensional dynamical systems. There is a critical need for a computational-experimental framework to
characterize the complex dynamics of naturalistic interaction and connect them across neural and behavior
scales. The main objective of this project is to develop a computational-experimental framework to construct
multiscale models of naturalistic social interaction connecting the spiking dynamics of neurons, brain
oscillations, body movements, and macroscopic behavioral states. To achieve this objective, the project will
utilize simultaneously recorded behavioral and electrophysiology data from ferrets during naturalistic
interaction. Ferrets are chosen as a model of dynamic social interaction for their high social skills and complex
visuomotor communication, which allows for fine-grained characterization of social dynamics based on
expressive body movements. At the neural level, ferrets’ frontoparietal networks exhibit similar oscillations to
those of humans that were found to synchronize during social interaction, paving the way to future comparative
studies. Animal data also provides the opportunity to include neuronal activity in the multiscale framework,
which is not commonly accessible in humans. Computationally, the toolbox will build upon recent advances in
topological time series analysis to extract states and transitions from complex dynamics at different scales of
measurements, combined with computer vision techniques for motion tracking, machine learning for cross-
scale mapping of state transitions, and expert annotations. This project integrates diverse perspectives from
cognitive social neuroscience to nonlinear dynamics, computational topology, and machine learning. The
project will significantly impact neuroscience by providing much-needed tools to examine multiscale relations in
the brain and behavior in real-world settings and the future design of state-dependent treatments for
neuropsychiatric and behavioral disorders, combining pharmacological treatments, brain stimulations, and
psychosocial interventions.

Public health relevance
Project Narrative BBQS R34 – Zhang & Frohlich Humans are complex systems whose health and diseases are affected by interacting elements across multiple spatiotemporal scales. This project is highly relevant to public health as it provides a computational- experimental framework to model behavior as a multiscale system – from neuronal activities and brain oscillations to body movements and social relations. In the long term, it will facilitate the development of precision medicine that integrates state-dependent interventions at all relevant scales.